INVESTIGATING THE ROLE OF THE CYTOSKELETON IN NEURODEGENERATION

Project Summary/Abstract:
Neurodegenerative diseases are among the fastest growing clinical burdens on society, and in the next 20 years
Alzheimer’s Disease (AD) is projected to overtake cancer as the second leading cause of death in adults. Despite
AD prevalence, there are currently no therapeutic interventions to combat the underlying pathology driving
disease progression. While much is still not understood about neurodegenerative pathogenesis, the
accumulation of extracellular amyloid- plaques and intracellular tau tangles are undisputed hallmarks of AD. To
combat disease progression, an attractive therapeutic strategy is to investigate impairments in native proteostatic
mechanisms used to dispose of this neurotoxic protein accumulation. One such mechanism which has been
implicated in the development and progression of not only AD, but numerous neurodegenerative proteinopathy
disorders including Parkinson’s and Huntington’s disease, is the autophagy-lysosomal network (ALN). The ALN
is a bulk degradative system utilizing vesicular transport to dispose of large protein aggregates which contribute
to neuronal dysfunction. This process relies on the active remodeling of the actin cytoskeleton to initiate, capture,
and transport neurotoxic cargo for degradation and maintain proper proteostasis. However, mechanistically how
dysregulations in cytoskeletal dynamics are associated with neurodegenerative pathology contributing to
disease remains unclear. Through multiple behavioral neurodegenerative screens, we have identified an actin
depolymerizing factor, cofilin, along with its upstream molecular regulators, which upon modulation improve
neurodegenerative behavioral deficits and lower tau accumulation in vivo. This proposal seeks to investigate
how cytoskeletal dynamics contribute to AD through genetic attenuation of the cofilin-centric cytoskeletal
remodeling pathway. I hypothesize that modulating the activity of cofilin and its regulators will ameliorate
AD neurodegenerative phenotypes via modification of the cytoskeleton and proteostasis. Aim 1 will utilize
behavioral and histological approaches to investigate how genetic modulation of numerous genes within the
remodeling pathway influence neurodegenerative phenotypes in tauopathy Drosophila and mouse models. In
Aim 2, I will investigate mechanistically how this cytoskeletal remodeling pathway is involved in the formation
and progression of the ALN through 1) measuring changes in neurotoxic protein accumulation upon cytoskeletal
genetic modulation using various tauopathy model systems, and 2) utilizing high resolution microscopy
techniques in AD patient derived induced pluripotent stem cells (iPSCs) along with biochemical in vitro assays,
to investigate how genetically modulating cofilin disrupts various phases of the ALN. Upon successful completion
of this project, we will identify molecular impairments of cytoskeletal remodeling associated with
neurodegeneration that are involved in proteostatic imbalances and disease pathogenesis. Furthermore, we
hope to identify novel therapeutic targets within this pathway capable of treating not only AD, but multiple
neurodegenerative diseases caused by neurotoxic protein accumulation.

Public health relevance
Project Narrative: Alzheimer’s disease (AD) is the most prevalent neurodegenerative disease and most common form of dementia throughout the world. One of the causative disease driving proteins of AD is the accumulation of tau tangles in the brain. The goal of this project is to determine how cytoskeletal remodeling genes influences the brain’s native protein clearance pathways to lower tau accumulation as a potential therapeutic target to treat disease.